STRUCTURE OFGPL2 FIBERS

The B. subtilis bacteriophage, ~29, has twelve appendages of a processed form of gp 12 which are involved in attachment to the cell. It is not known what the oligomeric state of these "fibers" is. It has been long thought that they were dimers, but most bacteriophage fibers have turned out to be trimers. Mass measurements by the STEM of purified gpl2 "fibers" should resolve this question. The purified gp 12 protein is 86 kDa by SDS-gel analysis and the native form is a dimer or trimer by sedimentation analysis. In a preliminary study, the fibers looked very nice but (inadvertently, because of a new filament) the dose was too high to obtain meaningftil mass measurements. This experiment is being repeated.